High-speed hyperspectral imaging for highly multiplexed immunofluorescence imaging

PROJECT SUMMARY
Pathology using immunohistochemistry (IHC) remains a critical tool in modern clinical medicine. However,
the capabilities of routine IHC methods have not kept pace with advances in biomedicine, which require
evaluating networks of, e.g., tens of large molecules (typically protein targets) in a tissue context by
multiplexing. To overcome this limit, highly multiplexed IHC imaging systems based on mass spectrometry and
repeated Immunofluorescence (IF) imaging have been developed. These systems claim theoretical
multiplexing of up to 100 targets. However, they are too slow, expensive, and complex, for routine use, and are
currently used in a small number of research laboratories.
We are working to radically change the capabilities of IF imaging to allow routine detection of tens of
molecular targets rapidly and at moderate cost. Our approach builds on our previous work on high-speed
hyperspectral imaging coupled with amplified molecular target labeling methods.
We will advance our technology and demonstrate its capabilities with a specific research application
involving imaging of brain sections from a mouse model of a neuropathology relevant for Alzheimer’s disease
(AD). We will make improvements to achieve simpler and faster operation of our technology. We will then
image up to 12 targets and demonstrate the ability to extend our approach to tens of targets on a single tissue
slide. We expect our instrumentation and protocols will be sufficiently simple, low cost, and rapid to allow
routine use in most pathology and research laboratories.
!

Public health relevance
PROJECT NARRATIVE This project will extend the high multiplexing capabilities, currently available in complex mass spec and repeated immunofluorescence (IF) imaging methods to a simple, low cost and rapid IF approach, in turn enabling widespread and routine use of multiplexed IF in pathology. In the near term, our approach will provide a powerful imaging tool to better inform research on a wide range of diseases. In the longer term, the approach will be extended to clinical pathology, where it could support better informed diagnosis and therapy selection for neurodegenerative, neoplastic, and other diseases. !